Effects of Flame Retardants on Brain Function and Attentional Deficits in School-age Children - Brain Imaging, Neurobehavioral, and Gut Microbiome Studies in a Longitudinal Birth Cohort

SUMMARY
The number of children diagnosed with attention deficit hyperactivity disorder (ADHD) has risen steadily, yet
preventable causes of ADHD remain largely unknown. Prenatal exposures to environmental chemicals,
including flame retardants such as polybrominated diphenyl ethers (PBDEs), have been increasingly linked to
ADHD, but their role in ADHD causation is controversial. Due to concerns about possible toxicity,
manufacturers have substituted PBDEs with newer chemicals, such as halogenated non-PBDE compounds,
that have not yet been investigated in human studies and thus could be even more threatening. The EPA
Report on Children and the Environment identified the possible link between flame retardants and ADHD as a
critical research gap that, if not promptly addressed, could keep millions of children needlessly exposed to
chemicals with possible long-lasting adverse effects. We will address this urgent priority by combining
behavioral assessments with state-of-the-art brain imaging—i.e., task-based functional MRI (fMRI), resting-
state fMRI, and diffusion MRI—to identify the influences of flame retardants on the functioning and organization
(i.e., connectivity) of children’s brains. This approach provides a significant advantage over previous studies of
flame retardants, which used only behavioral ADHD assessments or clinical diagnosis and may have failed to
detect preclinical alterations, underestimated effects, and provided scant neurobiological understanding. We
focus on pregnancy as a critical exposure window when toxicants are most likely to affect the developing brain.
However, we will also build upon new evidence demonstrating that the gut microbiome—a possible biological
target of flame retardants—modulates attention and impulsivity during childhood. Hence, we will also explore
whether exposures to flame retardants between 6-9 years of age—when ADHD most commonly presents—
adversely affect brain function and phenotypes by altering the child’s gut microbiome. To do so, we will
leverage the existing GESTE birth cohort, designed specifically to investigate flame retardant neurotoxicity in
children. GESTE has extensive prenatal and childhood exposure data and neuropsychological assessments at
6-7 years. We will reevaluate children (n=500) at 8-9 years, when the proposed MRI techniques are feasible
and more accurate testing for attention/impulsivity can be conducted. In Aim 1, we will determine whether
prenatal exposure to PBDE flame retardants is associated with MRI abnormalities in brain function and
connectivity and with ADHD behaviors and diagnosis. In Aim 2, we will determine whether prenatal exposure
to halogenated non-PBDE flame retardants is associated with MRI abnormalities in brain function and
connectivity and with ADHD behaviors and diagnosis. In Exploratory Aim 3, we will explore whether the levels
of PBDEs and their substitutes, measured in both blood and stools during childhood, are associated with MRI
brain measures, neurobehaviors and ADHD diagnosis via alterations of the gut microbiome. Our results will
help identify adverse chemical effects and protect millions of children in the U.S. and worldwide.

Public health relevance
PUBLIC HEALTH STATEMENT Current treatments reduce ADHD symptoms but are inadequate at preventing long-term sequelae, such as poor academic and social functioning, antisocial behaviors, and psychiatric hospitalizations. Hence, identifying new preventable root causes of ADHD is an urgent public health priority. If we were to observe adverse effects of flame retardants on brain function and ADHD, our study would help hasten the removal of items, including carpeting, curtains, furniture, and many others that continuously release PBDEs or other halogenated flame retardants in our homes—with immense potential benefits to millions of children in the U.S. and worldwide.